Penn Skin Biology and Diseases Resource-based Center

PROJECT SUMMARY
The Penn Skin Biology and Diseases Resource-based Center (Penn SBDRC) will continue to support and
accelerate skin disease research and its translation by providing critical infrastructure, resources, and expertise
to skin investigators. The overall goals of the Penn SBDRC are to promote collaboration among skin
investigators, especially across disciplines; to draw new investigators with diverse perspectives to skin
research; to foster an environment that supports and cultivates the next generation of skin researchers; to
increase access to technology and resources for conducting rigorous, impactful skin research; and to
accelerate translation of research findings into innovative therapies for skin disease. To accomplish these
goals, the aims of the Center are: Aim 1) To provide cutting-edge approaches and related expertise centered
around 3 multi-disciplinary Resource Cores: Cutaneous Phenomics and Transcriptomics (CPAT) Core, Skin
Translational Research (STaR) Core, and Data Science and Informatics (DSI) Core. These Cores are highly
synergistic, providing high-demand and/or specialized services, valuable tissue/cellular resources, and the
expertise to ensure rigorous experimental design, analytical strategies, and accurate interpretations. All Cores
take advantage of the deep expertise of the Directors and Co-Directors and their research groups, to
continuously improve and innovate upon techniques/approaches offered by the Center. Aim 2) To establish an
Administrative Core that unifies skin investigators and promotes the goals of the SBDRC. The Administrative
Core provides oversight and implements the activities of the center. This includes an Enrichment Program that
is subdivided into 4 Sub-Cores: The Community Outreach Sub-Core introduces underserved Philadelphia
public high school students to the excitement of biomedical research and dermatology through the Penn
Academy of Skin Health (PASH), a Saturday academy and summer internship program. These programs also
provide volunteer and mentorship opportunities for SBDRC members; The Mentoring Sub-Core promotes
career success and training through structured mentorship for trainees and junior faculty. Through a
partnership with the Dermatology Department’s Committee on Diversity and Inclusion, specialized mentoring
programs for women and minorities underrepresented in medicine will be provided, as well as training for
SBDRC mentors. The Scientific Enrichment Sub-Core sponsors a seminar series, workshops, and a yearly
scientific symposium to promote interactions, collaboration, and innovative approaches among skin
researchers. The Seed Funding Sub-Core offers 3 different funding mechanisms that attract new investigators
and support the independence of junior investigators. The Penn SBDRC leverages the excellence of Penn
Dermatology’s research and clinical programs as well as that of the entire Penn community to enhance
collaboration, bringing new technology to skin research, and providing access to critical intellectual and
technical resources that greatly enhance innovation and rigor in the study of skin disease. The Center impacts
skin research well beyond Pennsylvania’s borders, and ultimately advances the treatment, prevention, and
diagnosis of skin diseases.

Public health relevance
PROJECT NARRATIVE The Penn Skin Biology and Diseases Resource-based Center (Penn SBDRC) enables and accelerates skin disease research and its translation by providing critical infrastructure, resources, and expertise to skin investigators. The overall goals of this Center are to promote collaborative, multi-disciplinary research among skin investigators, to draw new investigators with diverse perspectives to skin research, to foster an environment that supports and cultivates the next generation of skin researchers; to accelerate and increase the impact of skin investigations by providing expertise, cutting-edge technologies, and valuable tissue resources for conducting rigorous skin research, and ultimately, to translate of research findings into innovative therapies for skin disease.